Auditory predictors of late language emergence

PROJECT SUMMARY/ABSTRACT
This is an application to NOSI NOT-DC-24-010 Tackling Acquisition of Language in Kids (TALK) R01
Research Projects. Delayed language emergence in the absence of other cognitive or developmental concerns
occurs in approximately 10-20% of children, often referred to as “late talkers”. Past research has shown that
starting intervention earlier, such as in the first year of life, leads to more optimal language and learning
outcomes. However, the identification of infants at a higher likelihood of language delay that would benefit from
intervention remains challenging. In this proposed project, we investigate whether early auditory brain or
behavioral measures can serve as prognostic predictors of later language outcomes. We will follow infants
longitudinally and obtain measures of auditory and linguistic abilities at 5 timepoints: 3, 6, 11, 18, and 30 months
of age. Of these infants, half will be at a low likelihood (LL; 10-20% risk) of having late language emergence and
half will have additional risk factors that will put them at a higher likelihood (HL; >20% risk) of late talking. At 3,
6, and 11 months of age, we will measure auditory brain responses to speech using electroencephalography. A
3, 6, 11, and 18 months, we will obtain a comprehensive assay of cross-domain development including auditory
skills, receptive and expressive language, cognitive, motor, and adaptive behaviors. At 30 months, we will
conduct a thorough language assessment including standardized assessments, a natural language sample, and
parent-reports of language and general development. Demographic and environmental variables with potential
influence on language outcomes including parental education, socioeconomic status, as well as parental stress
and adversity will also be obtained to provide necessary context for data interpretation. In Aim 1, we will
characterize the developmental trajectory for auditory brain responses to speech at 3, 6, and 11 months. In Aim
2, we will characterize the developmental trajectory for early auditory and language abilities at 3, 6, and 11
months and examine trajectory relationship with outcomes at 18 and 30 months. In Aim 3, we will identify brain
and behavioral measures that best predict 18- and 30-month language outcomes. This proposed research
addresses two TALK initiative objectives: 1) to advance our understanding of optimal measures for differentiating
developmental trajectories of children at high and low likelihood of late talking, and 2) to reveal early brain and
behavioral markers of language delay that may be evident in the first year of life. These results will determine
whether language screening in infancy is clinically feasible and if successful, has the potential to lead to improved
identification of infants at a higher likelihood of late language emergence, allowing for earlier intervention and
prevention.

Public health relevance
PROJECT NARRATIVE Delayed language emergence in the absence of other cognitive or developmental concerns occurs in approximately 10-20% of children. This project investigates whether early auditory brain or behavioral measures can serve as prelinguistic predictors of later language outcomes. If successful, these results may lead to improved identification of infants at a higher likelihood of late language emergence, allowing for earlier intervention and prevention.